HDAC9 nuclear/cytoplasmic shuttling in pulmonary vascular endothelial barrier regulation

PROJECT SUMMARY
Acute lung injury (ALI) is characterized by lung vascular endothelial (EC) barrier compromise resulting in
pulmonary edema. Gram negative (G-) bacteria are the source of bacterial toxins such as lipopolysaccharides
(LPS), which are potent triggers of ALI. Despite the use of potent antibiotics and aggressive intensive care
support, the mortality of LPS-induced ALI remains high, primarily because the complex molecular mechanisms
involved in EC barrier regulation are ill-defined. The Scientific Premise of this Project derives from our novel
preliminary data indicating that the class IIa histone deacetylase, HDAC9, is upregulated in the lungs of patients
with sepsis in concert with the inflammatory responses. Accordingly, the overexpression of HDAC9 in transgenic
mice increases basal lung vascular permeability and exacerbates vascular barrier compromise induced by LPS.
Conversely, deletion of HDAC9 gene improves lung function in LPS-induced murine ALI model. These data
suggest pro-edemagenic role of HDAC9 expression in ALI. HDAC9 is nuclear-cytoplasmic protein and its cellular
localization is regulated by phosphorylation. Phosphorylation leads to HDAC9 nuclear export thus inhibiting its
activity in the nucleus and promoting interactions with extra-nuclear targets. We demonstrated that LPS
increases HDAC9 phosphorylation accompanied by its nuclear export in EC. In contrary, de-phosphorylation of
HDAC9 leads to nuclear import thus inhibiting its association with cytoplasmic proteins. We showed that HDAC9
interacts with protein phosphatase 2A (PP2A), which has a barrier-protective role in EC. Further, our novel data
indicated that PP2A is activated by Gi-mediated EC barrier-protective agonists, HGF and the stable ATP analog,
ATPγS, suggesting the link between Gi-mediated signaling and PP2A in EC barrier enhancement. While the
mechanisms of Gi-mediated PP2A activation have not been described, our data suggest that they may include
the activation of GAB1/Shp2-mediated signaling. Further, both HDAC9 and PP2A interact with AJ protein
plakoglobin suggesting functional complex. However, whether the HDAC9-dependent EC barrier regulation
involved HDAC9/PP2A/plakoglobin interaction and EC barrier-protective effect of PP2A is mediated through
decreased HDAC9 phosphorylation is not yet established. Therefore, a primary goal of this Proposal will be to
define a novel role for HDAC9/PP2A crosstalk in AJ-mediated EC barrier regulation. We hypothesize that the
phosphorylation status of HDAC9 and its interaction with PP2A alter intracellular signaling to regulate the EC
barrier via effect on AJ assembly. The SAs are: 1: To evaluate the role of HDAC9 phosphorylation/nuclear export
in the LPS-induced adherens junctions-mediated endothelial barrier compromise in vitro and in vivo. 2: To
determine the importance of PP2A-mediated HDAC9 dephosphorylation/nuclear import in the assembly of AJs
and endothelial barrier strengthening in vitro and in vivo.

Public health relevance
PROJECT NARRATIVE Acute lung injury (ALI) and its more severe form, acute respiratory distress syndrome (ARDS) carry an unacceptably high level of mortality which results from the fundamental lack of effective pharmacological therapies. A common feature of ALI is the loss of endothelial barrier function in the pulmonary circulation, but a multitude of mechanisms underlie the pathological changes that contribute to pulmonary edema and complicates the investigation. This Project is focused on the novel role of cytoplasmic actions of histone deacetylase, HDAC9, in endothelial barrier regulation with the goal of accelerating the development of new therapeutic approaches.